Proteogenomic translator for cancer biomarker discovery towards precision medicine

PROJECT SUMMARY
The goal of our PGDAC is to improve our understanding of the proteogenomic complexity of tumors. Towards
this goal, our First Aim is to apply multiomics and network based system learning to reveal causative
molecular regulatory relationships contributing to varieties of phenotypes in cancer using CPTAC
proteogenomic data. We will start with rigorous preprocessing and quality control using a pipeline tailored to
MS-based proteomics data to detect and correct batch effects, outliers, sample labeling errors, as well as to
impute missing values (Aim 1.1). We will then utilize novel statistical tools to jointly model ≥6 types of omics
data to systematically characterize functional impact of DNA alterations (such as DNA mutations, CNA, and
methylations) (Aim 1.2). Such cis-/trans-regulatory networks will help us to elucidate how protein or pathway
activities are shaped by genomic alterations in tumor cells. We will also construct protein/PTM co-expression
networks based on global-, phospho-, glyco- and other PTM-proteomics data (Aim 1.3). When constructing
these networks, we will use and create advanced computational tools to effectively borrow information from
literature, publicly available open databases, and transcriptome profiles. Moreover, we will study cell type
composition from bulk tissue using novel multi-omics deconvolution analyses, and identify immune subtypes
with distinct immune activation or evasion mechanisms (Aim 1.4). Furthermore, we will perform comprehensive
investigation of kinase and transcription factor activities by leveraging publicly available data extracted and
processed from many regulatory network databases (Aim 1.5). All Aims 1.2-1.5 will contribute to a large
collection of functionally related protein/PTM sets, co-expression network modules, immune signatures, as well
as kinase/TF activity scores. These features and feature-sets will then be tested for their associations with
disease phenotypes (Aim 1.6). For all analysis tasks in Aim 1, we will derive an integrated view of
commonalities and differences across multiple tumor types via Pan-Cancer analyses. Our Second Aim is to
further develop methods, software, and web-based tools to optimize the data analyses of our PGDAC. We will
develop novel statistical/computational tools; implement these methods as computationally efficient and user-
friendly software; and construct an integrated data analysis pipeline (Aim 2.1). We also plan to develop a set of
web-based services for querying, visualizing, and interpreting analysis results from CPTAC studies (Aim 2.2).
Our Third Aim is to nominate novel protein-based cancer biomarkers and drug targets for further investigation
by targeted proteomics assays. We will first apply machine-learning-based prediction models on features and
feature-sets from Aim 1 to identify protein biomarkers that predict disease outcome, treatment responses, and
therapeutically distinct disease subtypes (Aim 3.1). We will also query disease related gene, protein, and PTM
signatures against function perturbation databases, such as the LINCS L1000 database, to prioritize small
molecules and drugs that could be tested for attenuating tumor growth or treatment response (Aim 3.2).

Public health relevance
PROJECT NARRATIVE The goal of this Proteogenomic Data Analysis Center (PGDAC) is to elucidate the regulatory molecular and cellular complexity underlying tumors by employing multiomics and network-based systems learning on CPTAC proteogenomic data. Our team brings together extensive expertise in systems learning and proteomics data modeling. The project will generate valuable resources including: (1) high-confidence candidate biomarkers and drug targets; (2) new knowledge of cancer biology that involves integrated genomics, transcriptomics, and proteomics; and (3) new bioinformatics tools that will aid in the mining, visualization, and interpretation of large-scale and complex cancer-related datasets.